Innovative Technology for MRI Guided Procedures

In FY25, we have continued to pursue catheterization procedures using our high-performance 0.55T MRI system configuration. We have worked in collaboration with Krishna Nayak’s lab at USC on the development of a 3D real-time MRI sequence, reconstruction, and visualization. This approach enables volumetric real-time imaging of the heart and interventional devices with 3D isotropic resolution for improved tracking and procedural guidance. We have collaborated with Dursun Korel Yildirim in Robert Lederman’s NHLBI lab to develop imaging methods for novel reverse polarization-based device imaging and deploy the method on the scanner. Our lab has also developed deep learning image reconstruction of spiral data sampling to enable real-time interactive spiral imaging with higher frame rate. Finally, we have continued our collaboration with Siemens Healthineers on higher performance gradients for 0.55T MRI-guided interventions and on the UI for image guided procedures.